An investigation of low-intensity focused ultrasound for addiction

PROJECT SUMMARY
Opioid use disorder (OUD) is a major epidemic in the United States and current pharmacological treatments
result in ~50% relapse. Alternative strategies are needed to isolate, target, and repair the specific brain circuits
implicated in craving and relapse. Low intensity focused ultrasound (LIFU) is a new method of non-invasive
neuromodulation that can be focused anywhere in the brain with high spatial resolution. Ultrasound can be used
to up or down regulate activity in specific brain regions and is currently approved for treating other disorders in
humans. The application of LIFU to modulate specific brain circuitry as an intervention for addiction is unknown.
The goals of this application are to determine whether LIFU has utility as an anti-relapse intervention in
a rat model of OUD and to learn about the neurochemical mechanisms that underlie its effects. One
specific region implicated in addiction is the dorsomedial prefrontal cortex (dmPFC). dmPFC glutamatergic
projections to the nucleus accumbens core (NAcc) underlie craving for many drugs, including opioids, as well as
time-dependent increases in craving (“incubation”) over protracted withdrawal. During early withdrawal, this
circuit is hypoactive and interventions that excite the dmPFC block the incubation effect. During late withdrawal,
this circuit is hyperactive and inhibition down-regulates activity and reduces craving. We propose to use inhibitory
or excitatory LIFU during the different withdrawal periods to modulate neuronal activity in the dmPFC – NAcc
circuit and reduce craving/vulnerability to relapse. In Aim 1, we will apply different doses of inhibitory and
excitatory LIFU to the dmPFC and measure neurochemical markers of dmPFC activity as well as specific
markers for dopamine and glutamate transmission in the dmPFC-NAcc pathway. Effects will be examined
acutely during early or late withdrawal, and then adapted to a 7-day treatment regimen. Next, using a 7-day
treatment regime, we will examine the effect of LIFU to the dmPFC during early (Aim 2) and late withdrawal (Aim
3) on vulnerability to relapse. Neurochemical markers will also be measured to relate brain activity to behavior.
Both males and females will be included. Based on previous research and preliminary data, our overall
hypothesis is that during early withdrawal, LIFU-induced excitation, but not inhibition, of the dmPFC will offset
deficits in neuronal activity and block the incubation of craving; whereas, during late withdrawal, LIFU-induced
inhibition, but not excitation, will decrease neuronal activity and block craving. Our long-term goal is to translate
LIFU into human clinical trials as an anti-relapse intervention for OUD. This application is a major step toward
this goal since the results will provide the necessary preclinical proof-of-concept data, as well as preliminary
evidence for its neuromodulatory effects.

Public health relevance
PROJECT NARRATIVE Opioid use disorder is a major epidemic in the United States; new, more effective, targeted treatments are critically needed to help prevent craving and relapse as current pharmacological treatments result in ~50% relapse. Focused ultrasound is a new, non-invasive, non-pharmacological method to modulate brain activity with high precision. Here, using an animal model, we will determine whether focused ultrasound can target and repair pathways that are dysfunctional in addiction to reduce craving and prevent relapse.